The MIT Center for Single-Cell Dynamics in Cancer (SCDC)

DESCRIPTION (provided by applicant): No abstract was provided.

Public health relevance
The experimental data and theoretical/computational models generated by this PS-OC will be used to better understand how regulatory networks are altered when a cell undergoes malignant transformation leading to cancer. It is anticipated that these advances will significantly advance medical science and treatment of cancer.